Molecular mechanisms of DNA replication in mitosis

SUMMARY
Each cell cycle, the genome must be faithfully duplicated and then divided appropriately into two progeny
cells. Most of the genome is replicated in S phase of the cell cycle, and the mechanisms of DNA replication are
well-characterized. However, cells sometimes have not finished replicating the entire genome as they enter
mitosis, the phase of the cell cycle when chromosomes are segregated eventually leading to cell division.
Instead, these remaining regions are replicated in mitosis in a likely “last-ditch effort” to produce separable
chromosomes: cells without it face aneuploidy or mitotic catastrophe.
Despite the importance of mitotic DNA replication, the mechanisms governing it are poorly understood. To
uncover the molecular mechanisms of mitotic DNA replication, our research program will use the biochemical
reconstitution of DNA replication using purified budding yeast proteins, which is ideally suited for addressing
direct mechanistic questions. We will complement this with yeast genetics approaches, known for their significant
contributions to our understanding of the cell cycle and DNA replication. Additionally, we have developed
innovative strategies that combine reconstituted replication forks with yeast cell extracts to discover novel factors
and explore the regulated timing of mitotic DNA replication.
Our model of mitotic DNA replication is a multi-step process starting with the regulated inhibition and
dismantling of the S phase replication machinery present at the replication fork to present a different structure
and make space for mitotic proteins. This dismantling is followed by regulated unwinding and cleavage events,
ultimately leading to a break-induced replication mechanism of strand-invasion, synthesis, and resolution. Our
novel and innovative approaches will test this complex model and determine the coordination of these steps with
other mitotic events occurring in distinct mitotic phases. We will also explore how and when mitotic DNA
replication particularly occurs at hard-to-replicate regions of the genome like chromosome fragile sites and
telomeres.
S phase replication and the proteins so far implicated in mitotic DNA replication are well-conserved, so the
mechanisms we uncover using the yeast system will provide a mechanistic framework that we will explore in
other contexts in the future. We are interested in how genomic factors such as chromatin state and the presence
of DNA damage or transcriptional conflicts play a role in mitotic DNA replication. Additionally, we seek to
understand how diverse cellular contexts like developmental stage or disease state result in variable reliance on
mitotic DNA replication, ultimately contributing to genome stability and cell viability.

Public health relevance
NARRATIVE While most of the genome is duplicated in S phase of the cell cycle, cells frequently finish replicating the remaining regions of the genome in mitosis through a complex yet poorly understood process. Without mitotic DNA replication, cells face aneuploidy or mitotic catastrophe. Our research program will use a combination of biochemical reconstitution and yeast genetics approaches to uncover the molecular mechanisms involved and understand the impacts mitotic DNA replication has on genome stability.